Mechanisms of Hepadnavirus Assembly and Replication

Abstract
Hepatitis B virus (HBV) is a major cause of chronic viral hepatitis that increases dramatically the risk of liver
cancer and other end-stage liver diseases such as cirrhosis. The major obstacle to curing chronic HBV
infection is the persistence of the viral episome, the covalently closed circular DNA (cccDNA), in the infected
hepatocytes despite antiviral treatment. This application will address viral and host control of HBV cccDNA
formation at a prerequisite step for cccDNA formation, i.e., the disassembly of viral nucleocapsids (uncoating),
which releases the viral relaxed circular DNA (rcDNA) for conversion to cccDNA. Three Specific Aims are
proposed. Aim 1 will define the viral capsid determinants of uncoating. Aim 2 will define the host determinants
of uncoating. Aim 3 will seek to understand, and to overcome, the failure of mouse hepatocytes to support HBV
cccDNA formation, so as to render mouse hepatocytes fully permissive to HBV replication and facilitate the
development of fully susceptible mouse models of HBV infection and replication.

Public health relevance
Project Narrative The hepatitis B virus (HBV) is a global cause of chronic liver diseases, including liver cirrhosis and cancer. We propose to elucidate the mechanisms of, and viral and host factors involved in, the disassembly of HBV nucleocapsid, which is an essential but poorly understood step in viral replication and contributes to the host tropism of HBV. These studies will bring novel insights into HBV nucleocapsid disassembly and and facilitate ongoing efforts to develop novel antiviral agents targeted at the viral capsids as well as mouse models of HBV infection.